Leica Stellaris 8 Confocal for Imaging Core

The University of Maryland College Park (UMD) requests $600,000 to purchase a critically-needed Leica Stellaris
8 FALCON (FAst Lifetime CONtrast) laser scanning confocal microscope. A diverse base of 14 Life Science
researchers (12 of whom are NIH-funded), who are all making significant and pioneering contributions to cross-
disciplinary research at the interface between cell biology, molecular biology neurobiology, developmental
biology, immunology, and host-pathogen interactions, will immediately benefit from the transformative imaging
capabilities of the instrument. Need for the instrument is great, as it will replace a well-used 14-year-old Leica
SP5x confocal that can no longer be upgraded and will lose guaranteed service support at the end of 2022. The
IC currently houses two other confocal systems, a 13-year-old Zeiss LSM 710 and a Zeiss LSM 980 Airyscan 2,
but the existing systems at UMD cannot accommodate all the imaging needs of the current SP5x users plus the
anticipated future needs of the major and minor users on this proposal, many of whom are starting new imaging
projects. The requested instrument is specifically designed to maintain the capabilities of the existing SP5x, plus
provide new cutting-edge technologies needed to enhance the users’ NIH-funded research beyond what is
currently possible via any other imaging system on campus. The Stellaris 8 will be equipped with a next-
generation pulsed white light laser, multiple high-efficiency Power HyD detectors, and integrated fluorescence
lifetime imaging (FLIM) software and support. The Stellaris 8 will be housed and maintained in the well-
established Imaging Core (IC), which is managed by an experienced facility director and is accessible to all UMD
faculty, students, and their collaborators. The IC makes significant contributions to NIH-supported research at
UMD by providing extensive imaging services ranging from advice on sample preparation to comprehensive
instrument training and assistance with image acquisition. The requested scanning confocal microscope will
advance current knowledge on a broad range of research projects, including host-pathogen interactions, the
molecular composition of synaptic connections in mammalian visual circuits, regulation of neuromodulatory
transmitters, protein trafficking, cell-cell communication, and the biology of extracellular RNAs. UMD has
dedicated significant matching funds toward the purchase of the instrument and operational support.
Furthermore, support at the departmental level will ensure that the instrument is covered under a service contract
for the lifetime of the instrument.

Public health relevance
This proposal seeks to replace an outdated laser scanning confocal system at the University of Maryland College Park (UMD) Imaging Core (IC) with a Leica Stellaris 8 FALCON confocal system. The superior capabilities of the proposed instrument will be used by a diverse group of NIH-funded researchers to investigate the interaction of hosts and parasites during infection, determine the molecular composition of synaptic connections in the brain, analyze gene silencing by extracellular RNAs for the treatment of human disease, monitor the real-time kinetics of protein-protein interactions, and study morphogenic signals in cell communication to create tissue patterns.